Anti-Xist RNP antibodies (AXA) in autoimmune disease diagnosis and prognosis

Project Summary
Substantial heterogeneity within autoimmune diseases and overlapping traits across diseases
have limited our ability to tailor effective therapies and sensitive diagnostics specific to each
autoimmune disease. Systemic lupus erythematosus (SLE), systemic sclerosis (SSc), and
dermatomyositis (DM) are three autoimmune diseases with a long history of challenges in disease
classification, prognostication, and therapeutic intervention. All three diseases are more prevalent
in females than males. This project leverages the recent discovery that patients with several
autoimmune diseases have elevated levels of circulating autoantibodies against the female
specific XIST ribonucleoprotein (RNP) complex, collectively termed anti-Xist RNP antibodies
(AXA). We will employ a newly developed protein array to comprehensively characterize AXA and
discover their diagnostic and translational potential. We will evaluate how patterns of AXA can
distinguish patients with SLE, SSc, vs DM, disease subtypes, and severity. We will further
evaluate the prognostic value of AXA in longitudinal progression of scleroderma, using carefully
chosen longitudinal samples of patients with early SSc. Finally, we will evaluate the predictive
value of AXA in the response of SSc to therapy. These studies will illuminate the diagnostic and
prognostic potential of novel autoantibodies against a female-specific RNP complex.

Public health relevance
Project Narrative Autoimmune diseases affect nearly 50 million Americans, and 80% of the patients are female. Several female-biased autoimmune diseases are challenging to distinguish and predict their clinical outcomes. This project will test whether a newly recognized type of antibodies circulating in patients’ blood improves the diagnosis and prediction of disease trajectories.